Obstetric Anesthesia and Postpartum Depression

The broad, long-term objective of the proposed project is to improve maternal health outcomes by
providing access to quality obstetric anesthesia care during delivery hospitalization.
Postpartum depression is a serious maternal health problem in the United States, affecting one in
seven parturient, especially racial and ethnic minority women. Severe postpartum pain is associated with an
increased risk of postpartum depression. Pain intensity and the risk of postpartum depression could be
reduced through the use of neuraxial analgesia for vaginal delivery (i.e., epidural or spinal analgesia) or
neuraxial anesthesia for cesarean delivery. Neuraxial analgesic or anesthetic techniques are the most effective
evidence-based interventions to relieve postpartum pain but are underutilized in racial and ethnic minority
women. Results of previous research are inconsistent on the association between the use of neuraxial
analgesia or anesthesia for childbirth and the risk of postpartum depression. Inconsistency of previous
research might be due to the non-consideration of newly identified strong risk factors for postpartum
depression, when estimating the risk of postpartum depression. Indeed, serious maternal complications during
delivery hospitalizations (i.e., severe maternal morbidity) and severe neonatal complications (e.g., preterm
birth, stillbirth) have been recently linked to a significantly increased risk of PPD. The hypothesized decreased
risk of postpartum depression associated with neuraxial analgesia or anesthesia for childbirth could be
modified when severe maternal or neonatal complications occur.
To untangle the interrelationships among neuraxial analgesia or anesthesia, maternal or neonatal
complications, and postpartum depression, we will analyze data from inpatient, outpatient, and emergency
department discharge records in New York State from 2006 to 2018 provided by the Healthcare Cost and
Utilization Project (HCUP) of the Agency for Healthcare Research and Quality. We will use sophisticated
statistical and epidemiologic methods, including causal inference techniques such as interaction and mediation
analysis, and stratify our analyses according to race and ethnicity.
The proposed project could provide scientific evidence for improving access to obstetric anesthesia
care, especially for racial and ethnic minority women, to reduce the risk of postpartum depression and
disparities in maternal mental health outcomes.

Public health relevance
Postpartum depression is a serious maternal health problem in the United States and severe pain after childbirth is recognized as a major risk factor for postpartum depression. The proposed project will help improve obstetric anesthesia care and pain management during delivery hospitalizations to reduce postpartum depression.